Polycystin-1 C terminal tail cleavage: Mechanisms and meaning

Summary
Autosomal dominant polycystic kidney disease (ADPKD) is one of the most common
potentially lethal genetic disorders, affecting ~1:1,000 people and producing end stage renal
disease in 50% of affected individuals. The disease is characterized by the formation of nephron-
derived fluid-filled cysts, whose initiation and expansion compromises the structure and function
of the remaining renal parenchyma. ADPKD is caused by mutations in either of two genes, Pkd1
and Pkd2, which encode polycystin-1 (PC1) and polycystin-2 (PC2), respectively. PC1 is an
extremely large membrane protein comprised of 4,302 amino acids that spans the bilayer 11
times. PC2 spans the membrane 6 times and is a member of the Trp family of non-selective cation
channels. PC1 and PC2 interact with one another to form a complex that localizes to a number of
subcellular compartments, including the primary cilium and the mitochondrion-associated
membrane domains of the endoplasmic reticulum. More than two decades after their discovery,
the principal physiological functions of these proteins and the processes through which their
dysfunction leads to cystic disease remain largely unknown. PC1 undergoes cleavages within its
N and C-terminal domains. C-terminal cleavage produces fragments that translocate to
mitochondria and to nuclei. We have found that transgenic expression of a protein corresponding
to the final 200 amino acid residues of PC1 (P200) in orthologous murine models of ADPKD
suppresses the cystic phenotype and preserves renal function. This suppression depends upon
an interaction between the C-terminal tail of PC1 and the mitochondrial enzyme Nicotinamide
Nucleotide Transhydrogenase (NNT). The discovery that a short fragment of PC1 reduces
disease severity in mouse models of ADPKD raises a number of exciting questions that will be
pursued in our proposed studies. To explore these questions we will 1) determine whether P200
expression suppresses cyst formation and reverses established cystic disease in multiple mouse
models of ADPKD; 2) determine how P200 affects mitochondrial function and cellular energy
metabolism; and 3) determine how PC1 C terminal tail fragments are produced in vivo and how
they affect metabolism and pathways involved in cyst formation. Addressing these questions will
provide important insights into the normal physiological functions of PC1 and will suggest new
potential targets for therapeutic development.

Public health relevance
Project Narrative Mutations in the gene encoding polycystin-1 cause most cases of Autosomal Dominant Polycystic Disease. The cleaved C terminal tail of the polycystin-1 protein enters mitochondria and expression of a protein corresponding to this cleavage fragment in a mouse model suppresses the development of cystic disease. The proposed studies will elucidate the mechanisms through which this fragment is generated and determine its effects on mitochondrial function and disease pathogenesis.